Identification of Genomic Changes Mediating Melanoma Development and Progression

The purpose of this project is twofold: first to determine the molecular basis underlying the genesis and progression of human malignant melanoma. The second, to identify novel genes associated with melanoma susceptibility in hereditary families. Melanoma has the fastest growing rate of incidence of any cancer in the Western world, and little is known about the molecular genetic changes underlying this important disease. This project can be divided into four component parts. 1) Molecular analysis of tumor progression. [This focuses on clonal progression identified by tissue array technology, CGH, and on clonal karyotypic alterations in malignant melanoma]. 2) Identification of genes differentially expressed during growth, differentiation and progression. [This focuses on suppression of tumorigenicity of melanoma, cDNA subtraction/differential display, retroviral-mediated reversion of tumor suppression, and DNA microarray analysis of differential gene expression]. 3) Genomic analysis of chromosome alterations. [This involves cloning of chromosomal breakpoints in melanoma, using microdissection and other molecular biology approaches]. 4) Analysis of susceptibility loci in hereditary melanoma families using linkage analysis {This involves genotyping of families with non-p16 melanoma to identify loci, and ultimately clone the genes conferring susceptibility to hereditary melanoma. - Cancer Research, Gene Mapping, gene mapping (HUMAN), Gene mapping (non-human), Genetics,Human Genome Research, - Human Subjects